A cross-species signaling system in tick immunity and development

Abstract
Borrelia burgdorferi (Bb), the pathogen of Lyme disease, cycles between mammals and ticks belonging
to the Ixodes scapularis species. During a tick’s bloodmeal engorgement on an infected host, Bb can enter
ticks and colonize the gut tissues. In our efforts to explore how ticks respond to invading Bb in the blood meal,
we discovered a cross-species communication pathway that enables I. scapularis to sense mammalian-derived
factors, such as the interferon-γ cytokine, that are ingested in the tick’s blood meal, which then bind a tick cell
surface receptor, subsequently triggering the tick JAK-STAT pathway. Once activated, this Dome1–JAK–STAT
signaling system not only enhances tick microbicidal responses against invading pathogens like Bb by
upregulating two antimicrobial proteins, a CLIP domain serine protease annotated as SP10 and a
domesticated amidase effector called Dae2, but also facilitates tick hematophagy and development. However,
despite our initial discovery, the mechanistic details of how this newly discovered pathway dually influence
vector immunity and development are missing, which constitute the focus of our current application.
The role of Dome1 in activating the JAK–STAT pathway is evident even in the absence of IFNγ
or Bb infection, suggesting that endogenous tick ligand(s) could bind and activate the pathway. In fact, our
preliminary data now identify a novel tick protein that acts as the native Dome1 ligand, termed herein as the I.
scapularis Dome1 ligand (IscDl). Dome1 is a multidomain protein with structural similarity to the vertebrate
class I cytokine receptors, which can act as "shared" receptors, recruiting multiple cytokines and mediating a
wide range of functions. Therefore, our first aim will define how IscDl-Dome1 interactions, individually or
cooperatively with the mammalian ligand (IFNγ), impact tick immune-developmental events.
The cross-species Dome1–JAK–STAT pathway specifically employs a Rho GTPase (called IGTPase)
to severely limit Bb levels in ticks via the induction of antimicrobial proteins SP10 and Dae2 via undefined
mechanisms. Based on our extensive new preliminary data, our second aim seeks to investigate the molecular
mechanisms of how these antimicrobial proteins individually or synergistically kill B. burgdorferi, limiting
bacterial persistence in vivo. We also seek to investigate the mechanisms of how the STAT–IGTPase cascade
exerts regulations of SP10 and Dae2.
Altogether, our study will provide new insights into the cross-species I. scapularis signaling
cascade, focusing on one of the first identified arthropod signal transducers with shared cytokines, as
well as immune-effector mechanisms with anti-Bb activities and their regulation, potentially contributing
to the future development of new interventions against tick-borne infections like Lyme disease.

Public health relevance
Project Narrative Borrelia burgdorferi, the pathogen of Lyme disease, cycles between Ixodes ticks and mammalian hosts and causes the most common vector-borne human infection in the United States. The project focuses on further mechanical dissection of a newly discovered mammal-tick cross-species signaling system that dually influences tick development and immunity, including anti-Borrelia responses. These studies expect to generate new biological insights about arthropod signal transducers with shared cytokines, as well as immune-effector mechanisms with anti- Borrelia activities, which will stimulate the future development of novel therapeutic strategies to combat prevalent tick-borne infections like Lyme disease.